Phase I Clinical Trial to Evaluate a Neisseria Gonorrhoeae Therapeutic Candidate

The Phase I Clinical Trial Units provide a vehicle for the investigation of new therapeutic agents for the treatment of infectious disease.